Improving Outcomes in the Breast Cancer Screening and Diagnostic Continuum

Specific subpopulations of U.S. women, including those with lower education, lower income, rural residence, and the underinsured experience higher breast cancer disease burden and lower survival rates than women without these characteristics, despite recent improvements in screening access and treatments. The majority of efforts to mitigate poor outcomes have focused on screening mammography access, but women must navigate multiple additional steps when cancer is suspected, including more imaging, biopsies, and specialist consultations. Each year, >12 million U.S. women enter this diagnostic care continuum. Failure to receive timely, quality evaluation leads to delayed diagnosis, more invasive procedures, advanced cancer stage at diagnosis, and greater mortality. Compared to screening, surprisingly little is known about drivers of patient outcomes during this diagnostic period. It is estimated that up to 30% of women with abnormalities detected by mammography fail to obtain appropriate or timely follow-up. A clearer understanding of the variable care and outcomes during the diagnostic continuum is hindered by the decentralized nature of breast cancer screening and diagnosis in the U.S., with differences in care likely due to a complex combination of individual, residential, and healthcare delivery factors.
We propose to conduct the largest U.S. observational study of diagnostic breast imaging to date. Specifically, we aim to 1) identify specific subpopulations of women with lower access to and use of key diagnostic imaging technologies; 2) determine differences in diagnostic outcomes that can serve as quality of care indicators across different subpopulations; and 3) identify differences in timeliness of diagnostic evaluation across different subpopulations. We will use multi-level statistical modeling and mediation analyses to account for multifactorial interactions that likely influence diagnostic care. Our team, the Breast Cancer Surveillance Consortium, consists of national experts in breast cancer epidemiology, biostatistics, health services research, medicine, and radiology. The BCSC represents the largest longitudinal breast cancer imaging data resource linked to long-term outcomes that is representative of the general U.S. population. We systematically collect woman-, exam-, residential-, practice-, provider- and tumor-level data across seven regional registries and more than 200 individual practices. With data collected for 13 million breast imaging exams, our team is well-positioned to carry out the proposed analyses. Our study will help shift the breast cancer screening research paradigm from focusing on screening access to evaluating the entire episode of care. By identifying novel quality of care metrics and “early warning” indicators of worse outcomes, our results will inform both practice-level interventions aimed at closing local quality gaps and national practice guidelines and policies directed towards more effective breast cancer diagnostic evaluation.

Public health relevance
Each year, more than 12 million women in the U.S. will be recommended for diagnostic work-up for concern of breast cancer and must navigate multiple steps including breast imaging tests, breast biopsies, and specialist consultations before diagnostic resolution. Compared to screening mammography, surprisingly little is known about how differences in breast cancer diagnostic work-up contribute to breast-cancer related morbidity and mortality. We will conduct the largest observational study to date on breast cancer diagnostic evaluation involving 1.4 million U.S. women across 198 individual practices to identify novel diagnostic quality of care indicators that can be used to develop interventions and guidelines aimed at closing breast cancer quality of care gaps.